INTRAVENOUS GAMMAGLOBULIN FOR IDIOPATHIC THROMBOCYTOPENIC PURPURA

Idiopathic thrombocytopenic purpura of both children and adults has been shown to respond to high dose intravenous gamma globulin therapy. This study proposes to test a beta-propiolactone treated preparation of intravenous gamma globulin in ITP. The advantage of this therapy over conventional therapy is the potential for elimination of virus transmission by beta-propiolactone treatment of this blood derivative.